Measuring and improving the innovative potential of research and translation through temporal knowledge graph embedding

Project Summary
Biomedical research relies on complex, evolving, multidisciplinary collaborations driven by researchers who
spend entire careers working at the moving frontiers of knowledge. The resulting innovations contribute
dramatically to human health, wealth and well-being. But increasing evidence suggests that marquee
successes are becoming more difficult and costly to achieve, a phenomenon commonly attributed to
substantial increases in the scale, scope, velocity and competitiveness of science over several decades. This
project (1) develops flexible computational, data and network science tools (2) integrated by a social scientific
framework to (3) analyze discovery and innovation dynamics and (4) improve individual and collective
capacities to identify and realize solutions for even wildly challenging problems. This use-inspired approach is
applicable across science, technology, engineering and mathematics (STEM) fields. Findings will thus
contribute to knowledge in network science, science of science, sociology and economics of science and
innovation and related fields while simultaneously offering new possibilities for application to the long, complex,
uncertain processes that characterize biomedical research and development (R&D). By employing advanced
techniques from network science, information theory, and machine learning, we aim to identify and predict
emerging opportunities for groundbreaking research—termed 'adjacent possibles'—and accelerate
transformative breakthroughs in biomedical fields and in science policies designed to improve human health
through research, innovation, and translation.
We examine the evolving social and conceptual landscape of research and its implications for
innovative possibility, the knowledge and collaborative dynamics of teams, their capacity to achieve novel
research aims and the sources and trajectories that yield long-term high impact disruptive findings. Results will
increase understanding of how biomedical R&D can more effectively harness diverse knowledge to achieve
disruptive scientific outcomes in critical areas such as mental health, addiction, and aging-related diseases.
Project outcomes will inform strategies to foster transformative biomedical research, identify and enhance
trajectories for high-impact translation, and thus contribute to human health. The resulting models and tools will
increase capabilities for identifying emerging research areas and assessing risk in research to help inform
policy, funder and investigator decision-making. This project directly addresses the National Library of
Medicine's call for innovative approaches to advance biomedical informatics and data science, potentially
revolutionizing our understanding of scientific innovation dynamics and informing evidence-based science
policy decisions.

Public health relevance
Project Narrative This project will benefit public health by developing advanced computational methods to model the evolution of scientific knowledge and predict how individual researchers and interdisciplinary teams contribute to groundbreaking discoveries in biomedical research at today’s frontiers and over decades. By modeling team dynamics, identifying emerging areas of innovation, and predicting long-term research trajectories, this use- inspired project will enhance funder and investigator capabilities to identify and successfully pursue novel, high-risk, high-return projects in biomedical and other STEM fields while contributing to fundamental knowledge in several related social and computational science areas. Improved models and tools can inform problem selection and team assembly strategies, potentially leading to breakthroughs in intractable but critical areas such as mental health, addiction, and aging-related diseases, ultimately improving public health outcomes.